Ultra-high field GluCEST MRI and MRS in youth at risk for psychosis

ABSTRACT: Psychosis commonly develops in adolescence or early adulthood. Malfunctioning
neurotransmitter systems, such as glutamate, are implicated in the disease progression of psychosis. Changes
in brain glutamate in psychosis likely have several sources, as such, many frontline antipsychotic medications
indirectly target the glutamate system and alleviate clinical symptoms. Unfortunately, monitoring in vivo
alterations of the glutamate system within the brain are spatially limited by traditional magnetic resonance
techniques. But, recently a novel 7T MRI technique (GluCEST) has shown that brain glutamate levels are
lower across the brain in youth on the psychosis spectrum and patients with schizophrenia as compared to
typically developing youth. Here, we propose to extend this novel work to directly measure glutamate within the
brain of patients at risk for developing psychosis. Thus, this proposal is motivated by the need to better
understand associations of brain neurochemistry, structure and function in both normal development and
during early psychosis. In this study, we seek to 1) compare measures of glutamatergic development across
the cortex in a cohort of typically developing (TD) youth, those at-clinical high-risk for psychosis (CHR) and
individuals with frank psychosis (PSY); 2) associate changes in brain glutamate with age- and diagnosis-
related structural network changes in those at risk for developing psychosis; and 3) to establish comparison
data of glutamate measures at 7T MRI (1HMRS vs. GluCEST). We will recruit and follow 35 TD, CHR and PSY
over the 5-year funding period. Imaging data will be acquired at 7T and analyses will leverage recent advances
in network science and machine learning. We believe this innovative approach can significantly advance our
understanding of the etiology of glutamate hypofunction in psychosis and provide advances to precision
medicine in psychiatry. Through the proposed multi-level analysis, this innovative research will provide a
substantial advance in our understanding of the neurodevelopmental substrates of psychosis.

Public health relevance
RELEVANCE: Psychosis is a debilitating psychiatric condition. Greater understanding of how abnormalities in brain development, such as disruptions in brain glutamate, during youth produce symptoms of psychosis or psychosis risk may be critical for the development of earlier and more effective treatments. This would benefit public health by reducing the great costs of psychosis to individuals and society at large.